Small RNA interactions with transgenes in genetically modified mosquito lines

Project Summary:
Strategies to use genetically modified mosquitoes for applications to control vector-borne disease rely on the
activity of a synthetic transgene that can encode new phenotypes, such as mosquito-killing or virus blocking
phenotypes. Observations that transgenes can unexpectedly lose functionality is consistent with regulation of
the foreign DNA by an RNA interference mechanism called the piRNA pathway. Preliminary small RNA
sequencing in transgenic line of both Aedes aegypti and Anopheles stephensi with such loss of function
phenotypes has revealed targeting of transgenes by siRNAs and piRNAs to different degrees. The goal of this
study is to identify potential small RNA activity against transgenes in mosquitoes and to directly test whether
such small RNA can repress transgene activity. The first aim is to assay for siRNAs and piRNAs by enrichment
and small RNA sequencing in the mosquito stages and dissected tissues that are relevant to transgene activity
and inheritance in both Ae. aegypti and An. stephensi wild-type and transgenic lines and to integrate that data
along with published transgene sequences into a bioinformatics resource that will support hypothesis testing in
other labs and contexts. A major output of this will be a resource that can allow researchers to design
constructs to avoid small RNA recognition. The second aim is to directly test whether siRNAs and piRNAs
detected in transgenic lines are repressive; we will do this using a transgenic sensor strain in each species
background, Ae. aegypti and An. stephensi. The strain will contain a genomic copy of with a fluorescent marker
designed to be detected by specific small RNAs. If small RNAs are repressive, the offspring of a cross between
the sensor strain and the test strain will result in decreased fluorescence. If siRNA and piRNAs are responsible
for this phenotype, knockdown of siRNA and piRNA biogenesis proteins DICER2 or Zucchini respectively will
rescue fluorescent protein expression. Activity from this cross will also be assayed by testing the abundance of
reporter transcripts as well as small RNAs produced against the reporter by sequencing, which can provide
information on whether repression is at the transcriptional or post-transcriptional levels. Broadly, this study will
begin to identify the breadth and impact of small RNA targeting in existing transgenic lines and lay the
foundation to explore how RNA interference in wild mosquitoes will respond to implementation of transgenic
technologies to control mosquito-borne disease.

Public health relevance
Project Narrative: Strategies to use genetically modified mosquitoes for applications to control vector-borne disease rely on the activity of a synthetic transgene that can encode new phenotypes, such as mosquito-killing or virus blocking phenotypes. Observations that transgenes can unexpectedly lose functionality is consistent with regulation of the foreign DNA by mosquito piRNA biology. This study will identify the breadth and impact of piRNA targeting in existing transgenic lines and lay the foundation to explore how the piRNA pathway in wild mosquitoes will respond to implementation of transgenic technologies to control mosquito-borne disease.